Influence of APOE4 genotype on microglial pathobiology and tau pathology after repetitive mTBI

One of the hallmark, chronic, features of repetitive mild TBI (r-mTBI) is the deposition of phosphorylated tau in neurons. Tau
lesions are also one of the main hallmark features of ADRD. It remains unknown what specific molecular triggers precipitate
the path towards this distinct TBI related neurodegenerative phenotype. The E4 allele is a major genetic risk factor for AD;
individuals carrying 1 copy have a 2-3 fold risk for AD, while those with 2 copies have a 15-fold risk compared to E3 carriers.
Despite some contradictory studies, the E4 allele has long been associated with a poor outcome after TBI, but the role played
by APOE in response to TBI is still unknown and well-designed longitudinal studies are needed. Conducting such studies in
humans remains challenging as epidemiological and prospective data are lacking, plus the heterogeneity of TBI etiology,
including (but not limited to) severity level, age, comorbidities and time post-TBI, present an enormously confounding
problem. Thus, the best way to address this question is in translationally relevant, well characterized and controlled animal
models, wherein key predisposing genetic factors can be targeted and expressed, and findings from longitudinal analyses can
be related to the limited autopsy information from human TBI cases who have died at different timepoints after their injury.
We have developed and characterized such mouse models of r-mTBI, which recapitulate many features of human TBI
pathology. In recent work, we have exposed human APOE-targeted replacement mice (APOE-TR), mice humanized for Tau
(TauKI) and crosses of these mice (E-Tau) to our r-mTBI paradigm, and observe TBI-dependent pTau pathology. From these
studies we have also revealed that the E4 allele augments the proinflammatory microglial response and Tau pathology in
injured mice compared to E3. APOE is upregulated in disease associated microglia, which has been reported in AD brains. In
our r-mTBI model we have also confirmed an increase in microglial specific APOE gene expression. Disease associated
microglia have been reported to drive the outcome and pace of APOE4-dependent neurodegeneration in AD transgenic
models; yet very little is known about their contribution in driving APOE4 mediated effects after r-mTBI. We will address these
unknowns using mouse models
expressing human forms of
APOE/Tau, and expose them to our r-mTBI paradigm to address
these timely and under-studied interactions. We will first expose these models topharmacological manipulation of microglia
using depopulation/repopulation paradigms to delineate their contribution to the APOE influence on r-mTBI pathogenesis
and tau pathology. In the next part of the study, we will use an inducible APOE-KI model to genetically manipulate
to delineate their contribution to the APOE influence on microglial
TBI mediated neurodegeneration, tau pathology and behavioral outcome.
microglia
specific APOE expression transcriptomic phenotypes and
ex vivo functional activities, We will finally compare
TBI-dependent microglial transcriptomic responses in the presence or absence of APOE deletion in this model to reveal
microglial specific targets that correlate with favorable outcomes after r-mTBI and represent novel therapeutic targets. We will
confirm the translational relevance of our targets in r-mTBI/control autopsy cases from different APOE backgrounds. Our
future work will interrogate the functional and therapeutic roles of these targets. This study is much needed as a first step in
deciphering the role of APOE4 in microglia pathobiology after r-mTBI, which is currently under-investigated.

Public health relevance
PERSONNEL JUSTIFICATION Joseph Ojo, Ph.D. (Principal Investigator, 3 calendar months per year) is a molecular and cellular biologist who has many years of experience with performing histopathological analyses of brain tissue. He has been involved in the development and characterization of a variety of mouse models of TBI, AD, PD and comorbid conditions, and performing molecular level analyses with novel omic technologies. He has been a key investigator on the original and current contracts with Dr. Crawford and along with Dr Benoit Mouzon and Andrew Pearson generated the preliminary data described in this proposal. Dr. Ojo will continue to work alongside Dr. Crawford in directing all aspects of this project and provide supervision and full oversight on the overall approach, mTBI animal modeling, histopathological and molecular analyses, and data interpretation for the experiments outlined in this application. He will also be responsible for overseeing all aspects of animal manipulation, injuries, and treatment, ensuring that the projects are executed in a timely fashion. He will also perform some of the histopathological and biochemical assessments in the animal models described in the proposal. Fiona Crawford, Ph.D. (co-Investigator, 0.6 calendar months effort per year at no cost) is a molecular geneticist and biologist with over 30 years of experience in researching neurological conditions including investigation of molecular and clinical aspects of Alzheimer’s disease (AD) and Traumatic Brain Injury (TBI). Dr. Crawford is the President and CEO of the Roskamp Institute and she directs the TBI Research program and polyomics programs at the Roskamp Institute. She will provide supervision on the overall approach, mTBI animal modeling, pathological studies, and data interpretation. In particular, she will interact with all the team members listed on this application and work along with Dr Ojo in providing oversight as they implement the work proposed in this application, including regular communication with the expert consultants (Loane and Bioinformatics Team). Andrew Pearson M.S. (Research Associate, 6 calendar months in Years 1 and 2) is the Roskamp Institute TBI Research Team’s Research Associate. He is experienced in animal handling and surgical procedures, as well as histopathological characterization, molecular analyses, (such as western blotting and ELISA), glial isolation, ex vivo cultures and omic analyses. He will assist in all experimental injury procedures and treatment schedules and conduct histopathological/molecular analyses with the supervision of Dr. Ojo. OTHER EXTERNAL COLLABORATORS David Loane, Ph.D. (Consultant to the project, at $2500 in Year 2) leads a multi-disciplinary research team dedicated to studying the complexities of traumatic brain injury (TBI), neuroinflammation and tissue repair. His research investigates the activation status and functional role of resident microglia and infiltrating immune cells in the injured brain, and how they contribute to ongoing neurodegenerative processes that promote long-term neurological dysfunction after brain trauma. The primary focus of his recent work has focused on elucidating the molecular mechanisms that regulate microglial/macrophage function with the goal of manipulating these cells to attenuate destructive pro-inflammatory responses, and promote protective pro-repair responses. Thus, his experience fits perfectly with the goals and direction of this proposed study. Dr Loane has experience in using a variety of animal models of TBI (including the Cre-LoxP model and the well described Hexb-creER mice) for flow functional genomic, neuropathology and flow cytometry based studies. He is well trained in brain neuroimmune biology, neuropathology, and molecular & cellular neurobiology, including single- population RNA sequencing (RNA-seq), and has been studying gene and protein expression profiles and their related functions in resident microglia and infiltrating immune cells over 15yrs. Specifically, he will serve as a consultant working with Dr. Ojo to advice on the use of the Cre-LoxP model, tamoxifen treatment paradigm, microglia ablation technique, and interpretation of microglia cell histopathology and RNAseq data generated from our models.